FABRICATION OF CARDIOVASCULAR DEVICES

Fabrication of small numbers of cardiovascular devices and components for preliminary study and the fabrication of preproduction quantities for evaluation by other Devices and Technology (DTB) contractors.